Chronic Lung Allograft Dysfunction: Role for Tumor Suppressor LKB1 in Exosomes

Project Summary/Abstract
Lung transplantation (LTx) is a therapeutic option for patients with advanced lung diseases. Long‐term survival
after LTx is, however, limited by chronic lung allograft dysfunction (CLAD). CLAD most commonly manifests
itself as bronchiolitis obliterans syndrome (BOS) and about 50% of recipients (LTxRs) will develop BOS within
5 years post-LTx. Epithelial-mesenchymal-transition (EMT) and fibrosis have been implicated in the
pathogenesis of BOS. We demonstrated that liver kinase 1 (LKB1), a tumor suppressor gene, is
downregulated in BOS but not in stable biopsies using both western blotting and aldehyde bead conjugated
exosomes by flow cytometry. We also demonstrated that LKB1 knockdown induces exosome release from
airway epithelial cell line, BEAS-2B, and another human airway epithelial cell line, HPBEC. Exosomes released
from LTxRs with BOS also induces EMT which was regulated by LKB1 in BEAS-2B and HPBEC. NanoString
analyses identified LKB1 knockdown induced PDGFRβ expression in human airway epithelial cells. We also
demonstrated that biopsies from BOS LTxRs had reduced LKB1 and increased PDGFβR with inverse
correlation. These novel findings indicate an important role for the tumor suppressor gene LKB1 in the
regulation of PDGFβR and, therefore, fibrosis development. Studies proposed using both clinical samples and
in vitro cell culture model, we will define the mechanism by which exosomes with downregulated LKB1
released from transplanted lungs mediate EMT leading to CLAD. Aim 1 of the proposal is to determine serially
whether inactivation of LKB1 in exosomes isolated from plasma from LTxRs with known risk factors (primary
graft dysfunction [PGD]), acute rejection [AR] and respiratory viral infections [RVI]) can be useful as a non-
invasive biomarker for LTxRs at risk for CLAD. Our hypothesis is that persistent downregulation of LKB1 in
exosomes will be a biomarker for LTxRs at risk for developing CLAD. The second goal is to determine and
quantitate exosomes with LKB1/AMPK1 using serial retrospectively stored plasma from LTxRs with known
clinical diagnosis will be a more sensitive marker for CLAD and to determine its potential to differentiate
restrictive allograft syndrome and BOS by defining their immunological and molecular properties. Our third goal
is to define the mechanisms by which loss of LKB1 results in EMT and upregulation of PDGFRβ and promotes
the pathogenesis of CLAD. Towards this; a) we will define the regulatory mechanisms suppressing LKB1 in
LTxRs with PGD, AR and RVI, risk factors for CLAD, and b) we will determine the mechanisms by which LKB1
downregulation leads to upregulation of PDGFRβ and its signaling pathways which contributes towards
development of fibrosis. Results from these studies will provide novel information for the role of LKB1, in EMT
and fibrosis related pathologies including CLAD following LTx.

Public health relevance
Project Narrative Based upon our novel findings that: 1) circulating exosomes released from lung transplant recipients (LTxRs) diagnosed with BOS induces epithelial mesenchymal transition of airway epithelial cells in an LKB1 dependent manner; and 2) our observed significant down regulation of LKB1 in the biopsies from LTxRs with BOS and inverse correlation with PDGFRβ. We will define the mechanism by which tumor suppressor, LKB1, participates in the development of chronic lung allograft dysfunction by determining signals leading to PDGFRβ upregulation and mechanisms leading to down regulation of LKB1. Studies proposed will employ both clinical samples from LTxRs and human airway epithelial cell culture models towards these goals.